Oral Microbe Genome Database

The purpose of this agreement was to mount a genome database and analysis unit and Web site (www.oralgen.lanl.gov/ ) for microbes involved in human oral health and disease. This resource was to serve the NIDCR research community primarily.